Administrative Supplement to Parent Grant: "Enhancing capacity in faith-based organizations to implement and sustain multilevel innovations to improve physical activity"

PROJECT SUMMARY/ABSTRACT
To realize the full potential of the Faith in Action intervention, and meet the goals of the National
Heart, Lung, and Blood Institute and the Office of Behavioral and Social Science Research, the
proposed Administrative Supplement examines novel moderations and mechanisms of change
hypothesized to influence the physical activity (PA) of Latina churchgoers. The aims are to: 1)
examine Faith in Action (e.g., Motivational Interviewing, group exercise) and organizational-level
(e.g., pastor support) mediators in relation to Latinas' PA and 2) evaluate promotoras'
personalismo as a moderator of Faith in Action in relation to Latinas' PA. From the first 8
churches enrolled in the trial described in the parent grant, we will invite churchgoing Latinas
(N=202) to complete baseline and 6-month surveys assessing mediators and moderators of
change. Also at 6 months, a subsample of enrolled participants (n=50) from both the Standard
and Enhanced conditions will be invited to participate in focus groups to contextualize our
quantitative findings. This approach is congruent with the goals of the parent grant to enhance
the capacity of faith-based organizations and increase PA levels.

Public health relevance
PROJECT NARRATIVE Physical inactivity is prevalent and chronic diseases impact Latinas at a disproportionate rate. The proposed study aims to examine mediators and moderators of a multilevel physical activity program in churches. Findings from the study will help us optimize the impact of the intervention by identifying the most potent intervention components.